Mechanistic studies into regulation of the copper chaperone CCS by phosphorylation

PROJECT SUMMARY
Copper is an essential nutrient and vital for numerous cellular processes, including respiration,
antioxidant defense, electron transfer, and protein quality control. However, its dysregulation can lead
to diseases like cancer and neurodegeneration. Cancer cells exhibit increased copper needs to
promote tumor growth, a process termed “cuproplasia.” In neurodegenerative diseases such as
Parkinson's and ALS, copper mismanagement has been linked to the formation of toxic protein
aggregates. One key protein in copper homeostasis is the metallochaperone CCS (Copper Chaperone
for Superoxide Dismutase), which is responsible for delivering copper to other proteins, including SOD1
for redox regulation and MEK1/2 for cellular growth and proliferation.
This proposal aims to investigate the regulation of CCS, focusing on its post-translational
modification at serine 245, a phosphorylation site that may impact copper coordination and SOD1
activation. The aims of this proposal are to (1) explore how phosphorylation of serine 245 influences
CCS copper-binding and transfer properties, (2) characterize the effects of this modification in cellular
models, and (3) identify the kinases and phosphatases responsible for adding and removing this
phosphorylation.
The project employs a multidisciplinary approach, combining protein chemistry techniques like
solid-phase peptide synthesis, biochemical assays, and cellular studies. These methods allow precise
manipulation of CCS, enabling precise mechanistic studies of the effects of phosphorylation on copper
binding. This work will provide insights into how copper homeostasis is regulated and open new
avenues for therapeutic interventions targeting diseases associated with copper imbalance, such as
ALS and cancer. This research will also offer training opportunities for junior researchers, especially
undergraduate students, enhancing their expertise in both chemical and biological techniques while
contributing to the broader understanding of metal ion homeostasis and its role in disease development.

Public health relevance
PROJECT NARRATIVE Metals are essential nutrients to sustain life, with an estimated one third to one half of all proteins in our cells characterized as metalloproteins that bind one or more metal ions for proper protein function. However, dysregulation of metal-dependent biological pathways has been linked to the development of numerous pathologies including cancer and neurodegeneration. This project focuses on studying how a particular protein, CCS - which helps regulate copper in cells - is modified and how these modifications affect its ability to function properly.